Mechanisms of neural patterning and the generation of neural diversity in the brain

Project Summary
To investigate the generation of neural diversity, we use the simple brain of Drosophila that has only 100,000 neurons
but can support complex behaviors and simple learning. The highly deterministic nature of Drosophila brain
development allows us to define general rules that control the generation of neural diversity and are applicable to
mammalian development, even when this is further modulated by activity-dependent plasticity. The genetic control
of optic lobe development can be investigated in depth thanks to the repetitive nature of the system, where information
from the 800 unit-eyes (ommatidia) projects to 800 parallel retinotopic columns that sequentially process the visual
information through more than 200 cell types. The generation of neural diversity results from the integration of three
mechanisms: (i) ~800 medulla neuroblasts (NBs) are patterned by the sequential expression of temporal transcription
factors that generate distinct types of neurons at each temporal window. (ii) NBs produce different neurons depending
on their location in the neuroepithelium: Spatial factors locally modify the outcome of the temporal series. (iii) Binary
fate choice via Notch signaling further diversifies the two daughters of ganglion mother cells (GMCs) born from each
NB division. In contrast, NB transitions in the mushroom body, a brain region involved in learning, are controlled by
extrinsic factors, generating fewer neuron types through the use of extremely long lineages. The broad context of this
proposal will address how basic principles of neurogenesis explain the vast diversity of neurons in the optic lobes
and the restricted diversity in the mushroom body, and will help us understand more complex brain structures and
instruct further studies in mammals. We will investigate the mechanisms controlling neurogenesis through 4 aims:
Aim 1: Temporal progression of neuroblasts: Timing and transition mechanisms: Temporal patterning is a
general mechanism to generate neural diversity in flies and vertebrates. We will identify all the temporal factors and
investigate their mode of cross-regulation that controls the timing of transitions.
Aim 2. Intrinsic specification of neuroblasts in culture: A given temporal transcription factor appears to control
the expression of the next factor in the series and to repress the previous factor to form a transcriptional clock
mechanism. We will use live imaging of transcription (MS2 system) and of protein expression in vivo and in cultured
NBs to investigate the intrinsic molecular mechanisms controlling the timing of transitions.
Aim 3. Specification of multi-columnar neurons: We will investigate how multicolumnar neurons are produced
locally in response to spatial factors while innervating the entire retinotopic map. We will also investigate how their
cell bodies move to distribute throughout the optic lobe.
Aim 4. Extrinsic cues for neuroblast transitions in the mushroom body: The mushroom body NBs have very
long lineages but produce a limited number of cell types. We will study how Ecdysone and Activin signaling mediate
extrinsic transitions between cell types and how they control gradients of RNA binding proteins acting in neuroblasts.

Public health relevance
Project Narrative Drosophila, with its genetic amenability and small brain size, yet sophisticated behavior, has been very successfully developed as a model system to study how neural circuits form. We investigate how neuronal diversity is generated in the optic lobes that contain more than two hundred cell types and in the mushroom body that has extremely long lineages. We will define the molecular mechanisms that specify the different neurons that process various aspects of visual information and define principles that will be applicable to other neural systems in more complex organisms.